ACTG 152--EDV VS DDI VS 2DV PLUS DDI IN SYMPTOMATIC HIV INFECTED CHILDREN

The purpose of this study is to compare the efficacy of therapy with ZDV versus ddI versus combination therapy of ZDV plus ddI in symptomatic HIV- infected children as determined by survival and disease progression (based on growth failure, changes in neuropsychological status or development of > 2 new or recurrent opportunitistic infections) prior to crossover.